Vaping in Childhood and Adolescence: Cognitive and Behavioral Consequences

Project Summary/Abstract
The long-term goal of this research program is to identify negative consequences associated with e-cigarettes
and other newer tobacco products, and reduce the health burden of tobacco use by developing interventions
and identifying policies to reduce youth use. This proposal focuses on e-cigarette use, which has increased
substantially and is now the most common nicotine product used by US youth. Our collective knowledge is not
yet sufficient to identify factors that can be targeted in e-cigarette interventions, or to be sure that we
understand the negative consequences of use. We propose to take advantage of the unique nature of the
ABCD study, which includes regular assessments of a large, nationally representative cohort from ages 9 to
19. The design of the study will allow us to examine a range of both (1) modifiable risk factors for e-cigarette
use and (2) behavioral, psychological, neurocognitive, and physiological consequences of use.
The goals of this study are to prospectively test the following hypotheses: (1) e-cigarette initiation and
progression in children is driven by modifiable social, contextual, and individual risk factors; (2) children who try
e-cigarettes will be more likely to become users of combustible tobacco products; (3) youth e-cigarette use is
associated with neural alterations and neurocognitive deficits; (4) e-cigarette use in adolescence is associated
with negative health consequences.
Our goals are twofold. First, we seek to identify modifiable factors among children that are associated with risk
of chronic tobacco use and dependence, in order to inform intervention development. Second, we aim to
delineate the extent to which e-cigarette use causes negative physical, behavioral and cognitive
consequences, in order to inform policymakers who have regulatory authority over tobacco products. The
overarching goal is to reduce tobacco use among youth and thus associated morbidity and mortality.

Public health relevance
Project Narrative The prevalence of youth vaping has grown substantially in the past decade, but knowledge of the drivers and consequences remains limited. Expanding this knowledge base is critical to developing effective interventions, which presently are lacking. We propose to leverage the unique ABCD cohort to (1) identify modifiable risk factors predicting e-cigarette use during childhood and adolescence, including social, contextual, and individual factors; (2) identify neurocognitive and health consequences of youth e-cigarette use; and (3) evaluate whether a causal relationship exists between e-cigarette and combustible tobacco use. Findings would aid development of prevention and intervention programs to reduce e-cigarette use and provide key information to agencies charged with regulatory decisions about e-cigarettes.